Individual lifestyle exposure as a determinant for the formation of biomolecule corona on nanoparticles

PROJECT SUMMARY / ABSTRACT
The proposed project aims to deliver a unique perspective to the process of non-specific
adsorption of serum biomolecules on intravenously administered circulating nanoparticles.
Nanoparticles are widely investigated for their ability to not only formulate water-insoluble or
enzyme-degradable drugs into an injectable solution, but also target the encapsulated
therapeutics to the tissue of interest. While the latter is mostly achieved via intentional modification
of the nanoparticle’s surface, recent findings have reported the presence of serum proteins non-
specifically adhered to the nanoparticle surface, a phenomenon termed protein corona, which
redirects the nanoparticles to non-targeted tissues based on the composition of bound proteins.
The identity and quantity of adsorbed proteins on nanoparticles is currently hypothesized to be
determined primarily from specific physicochemical properties of the nanoparticle. However, with
growing clinical and pre-clinical evidence of differential composition of metabolites and proteins
in blood serum depending on different lifestyle exposure, such as stress-inducing events, there is
an unmet need to evaluate the effect of various kinds and levels of serum biomolecules on the
formation of characteristic corona around any given nanoparticle formulation. To fill in the gap,
we will first utilize animal models with two different stress-related lifestyle exposures, mainly social
isolation and overcrowding, to fully characterize differential biomolecular composition in blood
serum (Aim 1). Then, we will use the same blood serum to incubate nanoparticles of defined
properties, evaluate the biomolecular composition in the corona, and analyze its relationship to
the initial metabolome and proteome profile in serum (Aim 2). Dr. Prokai will serve as a consultant
and support the metabolomics and proteomics analyses of the blood serum as well as
nanoparticle samples that the Kim group will prepare. This project brings in the complementary
expertise of two research groups to generate a new perspective to the biocorona formation in
intravenously administered nanoparticles, with the long-term goal of developing or selecting a
personalized nanoparticle design to intentionally promote the formation of specific organ-targeting
biocorona.

Public health relevance
PROJECT NARRATIVE There is an exponentially growing number of nanoparticles newly engineered and clinically tested to enhance the precision of treatment at the diseased tissue. At the same time, extensive pre-clinical evaluations of nanoparticles have provided more insight into how nanoparticles interact with biological systems, such as binding of blood proteins onto the surface of injected nanoparticles, and how such interaction may interfere with nanoparticle’s intended functions. The proposed project seeks to investigate the relationship between high-risk lifestyles of public health relevance, specifically obesity and stress, their effect on the composition of biomolecules in blood, and the resulting impact on nanoparticle’s surface.